The roles of Hsd3b7 and Foxp2 in Lower Jaw Development

Project Summary/Abstract
Development of a functional jaw requires precise shaping of the underlying skeleton and proper integration
with the musculature through tendons and ligaments. In the jaw, both the skeleton and connective tissues such
as tendons and ligaments derive from multipotent cranial neural crest-derived cells (CNCCs). My project
focuses on two novel mechanisms by which skeletal and connective tissue fates are balanced in the vertebrate
jaw. In a previous study, we revealed that the nuclear hormone receptor Nr5a2 functions to promote
connective tissue at the expense of skeletal fates in both the mouse and zebrafish jaw, yet the mechanisms by
which Nr5a2 represses jaw skeleton formation were unknown. By analyzing single-cell sequencing data of
nr5a2 mutants, I have identified the bile acid synthesis enzyme Hsd3b7 and the transcription factor Foxp2 as
two potential targets of Nr5a2 that repress Hedgehog-dependent induction of lower jaw cartilage. In Aim 1, I
test that Hsd3b7 functions as a jaw-specific repressor of Hedgehog signaling by depleting the Hedgehog co-
factor cholesterol from the cell membrane of tendon-forming CNCCs. In Aim 2, I test that Foxp2 competes with
the Hedgehog target Foxc1, with Foxp2 closing cartilage enhancers in the tendon-forming region of the jaw
that would normally be opened by Foxc1. My research will therefore show novel and jaw-specific mechanisms
by which two Nr5a2 target genes function upstream and downstream of Hedgehog signaling to pattern the
region of the developing jaw generating tendons and other connective tissues. These findings will shed light on
how alterations to Hedgehog regulation and chromatin accessibility may underlie human birth defects affecting
jaw development. The research project and training plan for the fellowship period have been designed to lay
the groundwork for my long-term goal of obtaining a position as a tenure-track professor at a top-tier academic
research institution. I will receive mentorship from Dr. Gage Crump, a leading scientist in zebrafish craniofacial
development. The experiments in this proposal will take place on the Health Sciences Campus of the
University of Southern California, which hosts vibrant communities of craniofacial and stem cell scientists.

Public health relevance
Project Narrative Craniofacial birth defects commonly arise due to altered patterning of the cranial neural crest-derived cells that form the jaw skeleton and connective tissues. This project investigates two novel jaw-specific mechanisms that regulate the proportion of skeletal and connective tissue cell types in the developing face. Findings from these studies will inform how altered Hedgehog signaling and chromatin accessibility contribute to a variety of birth defects affecting the jaw.